Treating Obsessive-Compulsive Disorder During the Perinatal Period

PROJECT SUMMARY/ABSTRACT
The perinatal period (pregnancy through one year after giving birth) is a time of significantly elevated risk for both
the onset and exacerbation of obsessive-compulsive disorder (OCD). OCD is debilitating and costly in the
general population, but for perinatal women untreated OCD confers a host of additional risks ranging from serious
delivery complications to deleterious health outcomes for both the parent and infant. Although effective
treatments for OCD exist, particularly Exposure and Response Prevention (ERP) and serotonin reuptake
inhibitors (SRIs), these treatments have not been systematically studied in perinatal women in part because
pregnant individuals have been excluded from clinical trials due to safety concerns. However, perinatal women
are physiologically and psychologically distinct from the non-perinatal samples on whom ERP and SRIs were
empirically tested, and there are many reasons to expect that the unique biological and psychosocial context of
perinatal women might undermine the efficacy, tolerability, and safety of first-line OCD treatments. Despite the
dearth of data and the numerous ways that perinatal-specific considerations alter the treatment context, both
pregnant and postpartum women suffering from OCD routinely present to real-world clinical settings seeking
treatment. To respond to this maternal and filial health crisis, research is urgently needed to determine if first-
line OCD treatments are effective, safe, and tolerable for perinatal women, and how standard care needs to be
tailored to fit the perinatal context. This proposal will leverage existing patient data collected as part of standard
care at a large naturalistic behavioral healthcare system to address this critical, yet difficult to study, clinical issue
and inform larger-scale randomized-controlled trials (RCTs) aimed at improving outcomes for birthing parents
and their families. Using the largest perinatal OCD sample to date (N = 94; 43 pregnant, 51 postpartum) and an
equal number of propensity-score-matched non-perinatal controls (total N = 188), this study will implement a
case-control design, retrospective chart review, and statistical modeling to evaluate the following aims: 1)
Determine which interventions are administered to perinatal patients with OCD in a naturalistic setting; 2)
Evaluate the efficacy, safety, and tolerability of first-line OCD treatments in the perinatal period; and, 3) To inform
personalizing efforts, explore how standard treatments are adapted for use with perinatal patients and whether
these modifications improve outcomes. This proposal is in line with the strategic research priorities set forth by
the NIMH pertaining to investigating personalized intervention strategies (Objective 3.2.A), establishing the
safety and efficacy of interventions for women at various phases of the reproductive cycle (Interest Area 3), and
the need for additional research on women’s mental health during the perinatal period (NOT-MH-21-270). This
study will provide preliminary data attesting to the safety, tolerability, and efficacy of standard and modified OCD
treatments in the perinatal period, thereby justifying the inclusion of pregnant participants in a larger-scale RCT
to be proposed in a subsequent R61/R33 application and informing the nature of the treatments to be evaluated.

Public health relevance
PROJECT NARRATIVE Obsessive-compulsive disorder (OCD) is a chronic and debilitating psychiatric condition associated with impaired quality of life and functioning, costing over $10 billion annually in the United States alone due to medical costs and lost productivity. During the perinatal period—a time of increased risk for OCD—untreated OCD is associated with even more deleterious outcomes for the parent, offspring, and family system. This study will impart an understanding of how to treat OCD safely and effectively during the perinatal period and will inform a planned program of research aimed at improving outcomes for birthing parents and their families and mitigating the significant burden of OCD on both the individual and society.